Research Training in Experimental Immunology

This is a competing application for our multi-disciplinary program for “Research Training in Experimental
Immunology” at the University of Michigan Medical School (UMMS) beginning its 30th year. Faculty preceptors
with interests in immunology and immunological mechanisms of disease are selected from 12 UMMS
departments, as well as the College of Pharmacy, Dentistry, and the Veteran’s Affairs hospital. Our senior
preceptors direct active, highly regarded laboratories with exemplary records of scientific impact and funding.
These preceptors have outstanding records in mentoring graduate students and postdoctoral fellows. In
addition, we have added highly regarded new investigators and will ensure they have ample guidance in
becoming accomplished mentors themselves. The Immunology T32 Training Program (ITTP) is directed by Dr.
Bethany Moore who has 10 years of experience directing the ITTP. The co-Director is Dr. Malini Raghavan who
also serves as the Director of the Graduate Program in Immunology (GPI) at UMMS. Dr. Shannon Carty will
serve as Assistant Director for the ITTP. Drs. Moore, Raghavan and Carty will work closely with the ITTP
Executive Committee, internal and external advisors, and the GPI Graduate Student Affairs Committee to advise
trainees, monitor curriculum and resolve any issues. The ITTP will continue to sponsor: 1) a weekly seminar for
students and postdoctoral fellows to present works-in progress, 2) a visiting professor monthly seminar where
invited guest speakers present their research and interact with program faculty and trainees, 3) ITTP Research
Colloquium courses which provide in depth training in experimental immunology methods and translational
immunology, 4) short courses for deeper learning in trainee-chosen topics and 5) programmatic activities
including a journal club, annual retreat, peer mentoring, career development and networking opportunities for
our trainees. The ITTP also provides training in responsible conduct and rigor and transparency in research and
is committed to recruiting and training mentees from underrepresented populations to facilitate the creation of a
diverse and talented pool of researchers for the next generation. In fact, Drs. Moore and Raghavan have training
with regards to best practices in this area and are highly involved in diversity, equity and inclusion (DEI) activities
campus-wide, particularly as they relate to evaluation of candidates and mentoring. Support is requested for 5
predoctoral and 3 postdoctoral trainees, an increase to reflect the growth in the immunology community at
Michigan, growth in the GPI enrollment, growth in our ITTP training faculty and increased demand for training in
this field. This ITTP program has been essential to the formation of the GPI at the University of Michigan and
our success is best measured by the outstanding publication and presentation records of our recent trainees and
the excellent postdoctoral, academic and industry positions they earn as they progress. Importantly, this is the
only T32-supported program specifically addressing immunology research at the University of Michigan.

Public health relevance
Immunology is the study of the body’s immune system and how it responds in states of health and disease. Many human conditions involve alterations of the normal function of the immune system including cancer, autoimmune diseases, infectious diseases, and transplantation. The purpose of this training grant is to instruct the next generation of scientists in the critical thinking and technical skills necessary to provide mechanistic insights into how the immune system functions, and how to manipulate the host immune response to the benefit of human health.